Development and function of corneal lens-secreting cells

The human cornea is a precisely curved transparent structure composed primarily of extracellular
matrix (ECM) that is able to refract light and focus it on the retina. Genetic defects in corneal development
contribute to visual disorders such as myopia, hyperopia and astigmatism, as well as more serious diseases
like keratoconus and corneal dystrophy. The power of genetic model organisms has been under-used to
understand corneal disorders because of a dearth of information about potentially appropriate models such
as the Drosophila corneal lens. The corneal lens is entirely made up of apical ECM that is secreted by a small
set of non-neuronal retinal cells. These cone and pigment cells develop from the same pool of progenitor
cells as photoreceptors, and express the same transcription factor, Glass. The process by which cells in the
retina diversify and execute different developmental programs is not well understood. In the first aim of this
proposal, Glass-dependent enhancers specific for cone and pigment cells will be combined with a
photoreceptor-specific enhancer to determine whether cell type-specific gene expression relies on
coactivators or on repressors. These other transcription factors will be identified by extracting their binding
motifs from a genome-wide set of cone and pigment cell Glass-bound enhancers obtained from Targeted
DamID experiments. Altering the normal timing of cone and pigment cell differentiation, which is controlled by
the steroid hormone ecdysone, disrupts corneal lens morphology. Preliminary data suggests that two
ecdysone-regulated transcription factors, Blimp-1 and Eip93F, have opposite effects on the progression of
differentiation. In the second aim, this hypothesis will be tested by looking for temporal changes in gene
expression in the retina in loss of function conditions for either or both genes. In addition, cell type-specific
Omni-ATAC will be used to examine how these transcription factors affect chromatin accessibility on cone
and pigment cell genes. These experiments will reveal how cell differentiation is precisely timed so that
corneal lens components can be deposited in the correct sequence. Finally, a major roadblock to using the
corneal lens as a model is the current lack of knowledge about the nature and organization of these
components. The third aim will begin to address this by building on recent advances in the transcriptomics of
retinal cells and in the biology of other cuticular structures. Components predicted to localize to different
layers of the corneal lens will be labeled with endogenous fluorescent tags and used to characterize the
organization of the corneal lens in wild-type and mutant conditions. In addition, mutations in genes that
encode major corneal lens components will be generated and analyzed to determine their effects on its
structure. These studies will reveal which molecular and structural homologies link the Drosophila corneal
lens and the human cornea, and will therefore provide an informed basis for using the corneal lens to
understand genetic diseases of the cornea and to devise potential treatments for them.

Public health relevance
Narrative Human vision critically depends on normal development of the cornea and its ability to focus light on the retina. Model organisms have been an important tool for understanding other human diseases, but a lack of knowledge has prevented them from being used to study disorders of corneal development such as myopia, hyperopia, astigmatism, keratoconus or corneal dystrophy. This proposal will investigate how the cells that produce the corneal lens of the fruit fly Drosophila differentiate and how the corneal lens itself is organized, with the goal of using this system to model human corneal diseases and test treatments for them.